Mitigating IRI-induced CMV reactivation by targeting endothelial stress responses

PROJECT SUMMARY
Cytomegalovirus (CMV) remains the most common viral infection in kidney transplant recipients leading to
significant morbidity and mortality despite preemptive and prophylactic anti-viral therapies. While anti-rejection
immunosuppressive therapy is considered a significant contributing factor of increased incidence of CMV
infection following kidney transplant, we show that ischemia/reperfusion injury (IRI) inherent to transplant is a
main trigger to induce CMV reactivation following murine transplantation of a latently infected graft, in addition
to its prominent role in delayed graft function and allograft rejection. Currently, no FDA-approved therapy is
available for IRI. The goal of our research is to identify cellular and molecular targets for the development of
tissue/cell-specific strategies to prevent CMV reactivation and improve transplant outcomes. Endoplasmic
reticulum (ER) stress and mitochondrial (Mt) dysfunction are two interconnected adverse events incurred in IRI.
Inhibition of ER stress regulates Mt function and attenuates kidney injury. Inositol-requiring enzyme-1α (IRE-1α),
a main transducer of ER stress, has been implicated in CMV infection. Data from our preliminary studies
demonstrate that downregulation of IRE-1α expression is associated with reduced kidney transplant IRI by
deletion of its upstream mediator (e.g., TLRs/Myd88). Additionally, we show that inhibition of Mt fragmentation
by knocking down dynamin-related protein1 (DRP1), a mitochondrial fission protein in ECs, reduced EC
activation and graft injury. Moreover, renal endothelial cells (ECs) are the frontline responders to IRI and also a
main cell type of CMV latency and reactivation, representing an appropriate target site. However, it has not been
investigated whether modulating ER stress and/or Mt function in graft ECs prevents CMV reactivation. The
objective of this novel study is to determine whether targeting IRE-1α and/or DRP1 attenuates IRI, thereby
preventing CMV reactivation in D+/R- kidney transplant. We hypothesize that CMV reactivation is initiated by
IRI-mediated aberrant IRE-1α dependent ER stress responses and DRP1 mediated Mt dysfunction in donor
renal ECs that harbor the latent CMV genome. We will use a preclinical mouse model of kidney transplantation
to test our hypotheses. In Aim 1, we will first investigate the role of donor-derived IRE-1α in IRI-mediated CMV
reactivation in rejection-free syngeneic transplants, and then in allogeneic transplants to address influence of
rejection response and in modulating donor EC transcriptome landscape. Additionally, we will investigate the
role of donor derived DRP1 in transplant IRI and CMV reactivation using a similar approach. In Aim 2, we will
determine the therapeutic potential of pre-operative tissue/cell-specific targeting of ER and Mt stress pathways
by leveraging nanocarrier delivery platforms to mitigate kidney transplant IRI, thereby preventing CMV
reactivation. Data from this study will lay the foundation for further studies in an ex-vivo perfusion system of
human kidneys towards a clinically translatable pre-treatment strategy for donor organ management to mitigate
IRI and reduce the risk of CMV reactivation, improving the current standard of care in solid organ transplantation.

Public health relevance
PROJECT NARRATIVE Cytomegalovirus (CMV) is the most common viral infection in kidney transplant recipients despite anti-viral prophylaxis, and CMV infection can exacerbate transplant rejection and increase the risk of graft loss. Cell stress mediated by early ischemia and reperfusion injury (IRI) during implantation of the graft can cause reactivation of latent CMV. The goal of this proposal is to identify specific cellular and molecular targets that are responsible for IRI-induced CMV reactivation and to determine the therapeutic potential of an innovative nanocarrier delivery platform to mitigate transplant IRI and prevent reactivation and subsequent dissemination of CMV, thereby improving transplant outcomes.